Project 1 Clinical Procedures to Support Research in Myasthenia Gravis (CAPTURE_MG)

PROJECT 1 ABSTRACT
The CAPTURE-MG study aims to overcome persistent challenges to define the natural history of MG in common clinical practice by embedding a novel MG-Toolkit into the Epic Electronic Health Record (EHR) system across multiple academic centers. This innovative toolkit is designed to enable standardized, efficient, and low-burden data capture at the point of care—benefiting both clinicians and patients. Modeled after the successful ALS-Toolkit developed by the CReATe Consortium, the MG-Toolkit employs SmartForms to harmonize clinical documentation across sites without disrupting clinical workflows.
The primary objective of CAPTURE-MG is to establish a sustainable, multi-center platform for deep phenotyping of MG patients and real-world evaluation of newly FDA-approved therapies. Specific aims include: (1) developing and deploying the MG-Toolkit for routine clinical use as well as creating a centralized, de-identified database and (2) assessing treatment effectiveness using outcome measures derived from real-world data.
By enabling consistent, high-quality data capture, CAPTURE-MG will generate a critical resource to support comparative effectiveness research, phase 4 trials, and biomarker discovery. The MG-Toolkit will enhance the ability to monitor treatment responses and adverse events in clinical practice, which is key to evaluating the utility and define the unmet needs of patients despite emerging therapeutics. Importantly, this platform will capture data from the general clinical practice at each study site, including those typically not qualifying for clinical trials, thereby improving the generalizability of research findings and deepening our understanding of MG treatment outcomes.
The success of CAPTURE-MG centers on strong collaboration with academic investigators, patient advocacy groups, and industry partners to ensure long-term adoption and scalability of the MG-Toolkit. By demonstrating the feasibility and impact of structured EHR integration in neuromuscular disease care, this study has the potential to transform how MG research is conducted and how care is delivered.